Biomechanical and neural mechanisms of post-stroke gait training

Stroke induces a cascade of neurophysiologic changes in cortical and spinal circuits that result in
biomechanical gait impairments (reduced paretic propulsion, footdrop) and gait dysfunction (reduced speed).
While increasing gait speed is a major goal of stroke gait rehabilitation, targeting walking speed as a primary
gait rehabilitation outcome without regard to biomechanical and neural mechanisms fails to meet the emerging
standards of precision medicine, which is the future of rehabilitation research. Thus, here, we will confirm a
novel theoretical framework regarding neurobiological (top-­down) and biomechanics (bottom-­up)
mechanisms of how 2 gait treatments improve walking speed post-­stroke. Fast treadmill walking (Fast), a well-­
studied and clinically-­used intervention, improves gait speed. However, Fast-­induced speed improvements in
people post-­stroke may occur at the cost of inter-­limb asymmetry, energy inefficiency, and maladaptive
neuroplasticity. Recent work has demonstrated that combining Fast with functional electrical stimulation
(FastFES) not only leads to improvements in gait speed but also reduces energy cost (EC) of stroke gait.
Because reduced EC is crucial for sustaining faster gait speeds and promoting community activity,
biomechanical factors influencing EC post-­stroke merit more in-­depth study. Building upon knowledge gained
from previous FastFES work and our preliminary data, Aim 1 will test our hypothesis that in contrast to Fast,
FastFES promotes greater use of the paretic leg for forward propulsion, thereby improving inter-­limb
biomechanical asymmetry, which we hypothesize reduces EC. Gait rehabilitation essentially involves retraining
the central nervous system. Our lack of understanding of neuroplasticity mechanisms underlying gait
interventions continues to be a barrier to improving gait rehabilitation outcomes. Aim 2 will determine, for the
first time, if and how FastFES and Fast modulate excitability of neural circuits impacted by stroke and
implicated in locomotor control. Stroke leads to decrease in lesioned motor cortex (M1) excitability and
corticospinal tract (CST) output, and elevated spinal reflex excitability. New findings from our lab suggest that
unlike Fast, FastFES enhances lesioned CST and M1 excitability, restoring more normal CST output. FastFES
and Fast also differ in their effects on spinal excitability. Like most gait treatments, Fast and FastFES must
contend with high inter-­individual variability in treatment responses (a subset of participants are “non-­
responders”). Aim 3 will address whether baseline measures or short-­term changes in neurophysiological
biomarkers (CST and spinal excitability) can predict long-­term training-­effects. Results from our mechanism-­
focused clinical investigation will elucidate how, why, and for whom Fast and FastFES induce clinical benefits.
The overall impact of this work will be future development of cutting-­edge gait treatments that are individually-­
tailored based on neurobiological, biomechanical, and clinical characteristics to improve both gait quality and
gait function, well-­aligned with the NICHD mission of improving health through ‘optimal’ rehabilitation.

Public health relevance
Although brain and spinal circuits play important roles in recovery of walking after stroke, if and how these circuits change in response to gait treatments is poorly understood. This project will evaluate how two clinically- relevant rehabilitation treatments change walking patterns, brain and spinal circuitry, and walking efficiency in stroke survivors. By explaining why and for whom the treatments improve walking function, this project will help develop more effective treatments that improve both walking speed and walking quality, i.e. enable stroke survivors to walk faster and better.